Identification of cognitive decline and dementia: Prediction by everyday driving behaviors and physiological responses

As the population continues to age and rates of late-life cognitive impairment rise, early detection of cognitive
impairment is increasingly important for the timely implementation of interventions and safety initiatives. This
may be particularly important in individuals found to have high brain amyloid burden, putting them at particular
risk for Alzheimer’s disease and related disorders (ADRD) of the brain. Performance changes in challenging,
complex, high-stakes daily activities, such as driving, and accompanying physiological responses may together
provide an inexpensive avenue for early detection. This may serve the dual purpose of alerting individuals or
health care providers to early cognitive impairment, as well as to potential safety issues. Sophisticated in-car
technology that is increasingly becoming standard in new vehicles may provide the means to unobtrusively
capture sensitive information about naturalistic driving behaviors and potentially assist with early detection of
cognitive impairment. The proposed study will apply a novel approach to unobtrusively monitor older drivers in
(a) naturalistic, (b) fixed course, and (c) simulator driving situations. Machine learning approaches will be used
to select key features of driving behaviors and physiological measures of arousal in all driving scenarios and
eye tracking measures from fixed and simulator drives to predict drivers’ clinical diagnosis: young adult drivers,
healthy older drivers with and without high amyloid burden, and drivers with mild cognitive impairment with
evident amyloid burden. The participants will be followed longitudinally in the Michigan Alzheimer’s Disease
Research Center (MADRC) with annual cognitive and neurological evaluations, as well as repeat driving and
physiological testing at two years from baseline. Understanding and identifying changes in driving behaviors
and how these predict who will develop clinically identifiable cognitive impairment will lead to the development
of a model for early detection of cognitive decline and ADRD.

Public health relevance
This study will examine everyday driving behaviors and physiological measures obtained by in-car monitors during common driving situations (e.g., intersections, freeway ramps). The goal is to build a model that uses features from these in-car measures to detect small driving changes that may be the earliest indicators of cognitive decline and dementia in older adults. Utilizing data gathered unobtrusively from vehicles is cost effective, readily available, and may alert individuals and health care providers of early cognitive concerns, as well as potential safety issues.